Contribution of chromosome versus gonadal sex to bone mass and strength

SUMMARY
Skeletal dimorphism can be seen under physiological conditions and following genetic manipulations at the
structural, cellular, and molecular levels. Understanding the basis for these differences is crucial to developing
approaches to prevent and reverse the loss of bone mass and strength, tailored specifically for females and
males. We have shown lower total, femoral, and spinal BMD in female wild type C57BL/6J mice compared to
male littermates from 1 to 4 months of age. Further, µCT analysis in 4-months mice showed lower TbN, and
higher TbSp in distal femur of female compared to male mice. The differences are further enhanced in 20-months
mice, with changes in these parameters and lower BV/TV in female mice versus male littermates. Similarly, the
consequences of genetic manipulations differ between male and female skeleton. The difference in bone struc-
ture and composition between sexes has been ascribed to disparate sex steroid actions. Sex steroids interact
with their receptors in bone cells to directly modify gene expression and intracellular kinase activation, and indi-
rectly engage other signaling pathways and mechanical signals. Yet, sex steroid receptors deletion from bone
cells has not provided a clear understanding of the mechanisms underlying sexual dimorphism. This evidence
suggests that factors other than sex steroids such as chromosome sex contribute to the differences in bone
between males and females. Yet, a key question that remains unclear in our field is whether chromosome sex
contributes to sex-specific skeletal differences. The four-core genotype (FCG) mouse model, in which the testis-
determining gene Sry was deleted from the Y chromosome and/or expressed as a transgene (TG) comprises
mice of 2 gonadal sexes: male XXM (Sry TG) or XYM (YSry-/Sry TG), and female XXF (wild type) or XYF (YSry-).
Studies with these mice uncovered chromosome sex effects on the brain, on lifespan, and on adiposity, unrelated
to the sex hormone present. Yet, gonadal versus chromosome sex contribution to bone development and mainte-
nance with aging is unknown. Our long-term goal is to understand the basis for bone sexual dimorphism, and
how sex differences affect the growing and aging skeleton. We will test the hypothesis that bone mass and
strength accrual and decline result from a combination of gonadal and chromosome sex-dependent
mechanisms, by pursuing 2 Aims. Aim 1 we will determine the contribution of gonadal versus chromosome
sex to bone mass and strength in 2-, 4-, and 20-months FCG mice. Aim 2, will identify the molecular mech-
anism for sexual dimorphism in adult bone tissue in 4-months FCG mice, by testing the contribution of the
gonadal/chromosome sex to protein secretion and gene expression in bone cells. These studies will advance
our knowledge of the mechanisms controlling bone cell function in a sex-dependent manner during growth, skel-
etal maturation, and aging. Further, the results of the studies could inform on potential ways to improve bone
health in a gender dependent manner and might provide the basis for improved therapies to maintain bone health
in people with gender dysphoria, with circulating sex hormones that do not correspond to the chromosome sex.

Public health relevance
PROJECT NARRATIVE The skeletal phenotype differs between males and females under physiological conditions as well as following genetic manipulations not only at the structural, but also at the cellular and molecular levels. However, whether the sex differences stem from presence of ovaries versus testis (and the corresponding sex steroids) or the presence of two X chromosomes versus one X and one Y chromosomes (or a combination of both gonadal and chromosome sex) remains unknown. Understanding the basis for these differences is crucial to developing approaches to prevent and reverse the loss of bone mass and strength, tailored specifically for females and males.